A probe-based higher order multiplex technology to expand the capacity of digital PCR systems

Abstract
Absolute quantification of a DNA or RNA biomarkers of interest is needed in many biomedical
applications. Digital PCR (dPCR) provides ultrasensitive and absolute nucleic acid quantification of DNA or
RNA biomarker of interest and is becoming a popular tool with wider utility, especially, where absolute
quantification is essential. Some of the dPCR applications are detection of rare allele, measurement of copy
number variation and gene fusions, viral titer measurement, quantification of next-generation sequencing
libraries, and detection of rare targets from environmental samples such as wastewater. Currently available
dPCR systems are limited by the availability of optical channels and comes with high cost; instrument and
consumables, and thus, has a negative effect on clinical and hospital laboratory operation. Therefore, there is
a need for a reliable higher order multiplexing method that decreases the cost, maximizes the capacity,
decreases the lab operational burden, requires small quantities of precious clinical samples, and reduces the
environmental waste (decrease in environmental waste from reduction in plastics and chemical reagents).
Currently, higher order multiplexing in digital PCR is achieved by amplitude modulation, requiring a
complex data analysis tool, thorough optimization of probe concentration, and multiple controls. Our Zip-MeltTM
Multiplex Probe Technology (Zip-MeltTM MPT) - a probe-based higher order multiplexing method, provides a
simple alternative solution. The goal of this Phase 1 application is to develop high multiplex digital PCR method
for detection of important gene fusions using innovative Zip-MeltTM MPT. To demonstrate the feasibility,
herein, we chose quantitative detection and discrimination of four BCR-ABL1 fusion gene variants important for
monitoring of chronic myeloid leukemia utilizing just one optical channel, followed by performance
characteristics studies in comparison to the Comparator Method. The proposed studies will demonstrate and
mature our proprietary probe-based simple multiplex platform for quantitative detection of multianalytes in a
single dPCR reaction/well to measure residual diseases for diagnosis or monitoring of cancer.

Public health relevance
Project Narrative Inexpensive multiplex and quantitative technologies for minimal residual disease of various cancer is an unmet clinical need. Digital PCR (dPCR) provides a solution, but its capacity is currently limited leading to higher operational costs for the hospital and clinical laboratories. The goal of this proposal is to determine the feasibility of expanding the capacity of dPCR systems using Zip-MeltTM Multiplex Probe Technology (Zip-MeltTM MPT). The Zip-MeltTM MPT is a simple, sensitive, quantitative, and rapid chemistry-based platform to achieve high multiplexing. To demonstrate the feasibility, gene fusions [(breakpoint cluster region-Abelson (BCR- ABL1)], important in diagnosis and monitoring of chronic myelogenous leukemia (CML) and acute lymphoblastic leukemia (ALL) will be studied. Absolute quantification of BCR-ABL1 fusion is also essential for deciding treatment response. Our unique platform will provide cost-effective multiplex and absolute quantification dPCR assay for BCR-ABL1 fusion variant monitoring and also to monitor other diseases in the future.